Off-the-shelf CAR-T Therapy via Tumor-Selective Immuno-engagers

PROJECT SUMMARY
Today, there is renewed hope that mortality associated with various cancer types will be dramatically reduced
based on the potential success of novel immunotherapeutic agents, such as chimeric antigen receptor (CAR)-
expressing T cells. In some cases, the response from immunotherapeutic agents has been more robust and
sustained relative to traditional cancer chemotherapeutics.
Despite these successes – albeit very uneven across patient populations – adoptive cell therapy will remain
confined to a relatively small subgroup of patients until two of its major hurdles are overcome: (1) the reliance
on narrow differentiation between cancer and healthy cells due to the lack of bona fide, targetable, tumor-
specific markers, and (2) the lack of common targetable tumor biomarkers among all patients.
Here, we will exploit the inherent acidic microenvironment and negatively charged membranes of cancer cells
by using the pH(Low) Insertion Peptide (pHLIP), a peptide that selectively anchors onto cancer cell surfaces, to
selectively graft the surface of cancer cells with a non-native epitope for recognition and destruction by cognate
CAR-T cells.
At each stage of structural iterations, agents will be selected based on their chemico-physical properties,
efficacy in recruiting CAR-T cells, induction of selective toxicity towards cancer cells, and in vivo tumor
targeting and efficacy. The proposed work will combine areas of ongoing research in our respective
laboratories: specific delivery of synthetic immuno-engager agents to tumors based on their inherent acidity
(Thévenin), and discovery and clinical testing of CAR-T immunotherapy (Snook).
Given the critical need to improve on current cancer immunotherapeutic modalities, we anticipate that the
successful development of our system has the potential to extend treatment options to many cancer patients,
as it would allow for (i) off-the-shelf strategies based on a single and common exogenous antigen, (ii) a
standardized genetic manipulation of patients' T cells, (iii) streamlined clinical evaluation of therapies for a
larger set of human tumor types, and (iv) the production of these therapeutics at a scale that is commercially
viable.

Public health relevance
PROJECT NARRATIVE The lack of clear and viable tumor-specific antigens continues to significantly hamper progress of cancer immunotherapies, including the translation of therapies based on chimeric antigen receptor (CAR)-expressing T-cells. With the goal of establishing a selective, off-the-shelf, and safe CAR-T cell therapeutic strategy against solid tumors, we propose an entirely novel modality using agents capable of selectively tagging tumors based on their inherent acidity and surface net charge with a non-native antigen recognizable by its specific CAR on engineered autologous T cells. The proposed agents potentially represent a highly efficacious and low side- effect treatment that will be applicable to a wide-range of solid tumors.